IGF::OT::IGF ICF - HHSN261201200010I, Task Oder 27 - NCI Workforce Analysis Communication Products for the National Cancer Institute Division of Cancer Control and Population Sciences; Period of perfo

NCI Workforce Analysis Communication Products for the National Cancer Institute Division of Cancer Control and Population Sciences